The Impact of Obesity on Radiotherapy Anti-Tumor Effects

Abstract
Obesity has reached pandemic levels in the United States and will soon surpass smoking as the number one
cause of preventable cancer. Understanding how to best treat obese cancer patients is a critical unmet need.
Preclinical data from our lab show increased resistance to radiotherapy (RT) in obese mouse cancer models.
Clinical data demonstrates that obese cancer patients are more resistant to radiotherapy and have higher rates
of recurrence. Very few mechanistic studies have addressed these findings and understanding the mechanisms
governing radiotherapy resistance in obesity is a gap in knowledge. Our prior studies demonstrate that obesity,
likely via leptin, a hormone elevated in obesity, can alter the proliferation / survival of cancers and also change
the immune response to cancer, leading to changes in the efficacy of cancer therapies. Obesity suppresses
adaptive T cell anti-tumor immunity and the immune system strongly contributes to the anti-tumor effects of RT,
providing a potential mechanism linking obesity and RT resistance. Obesity related adipokines can induce anti-
apoptotic factors and RT resistance. Based on these observations we hypothesize that obesity induces
resistance to RT directly by increasing anti-apoptotic factors in cancer cells and indirectly by inducing
suppression of adaptive anti-tumor immunity in the tumor microenvironment (TME). We also hypothesize
that leptin signaling may mediate the RT resistance observed in obesity. This proposal seeks to test these
hypotheses and further delineate mechanistic links between obesity and RT resistance using three specific aims.
We will use lean and diet induced obesity (DIO) mouse models, immunosuppressed mice (Rag2 -/-), as well as
mice that lack functional leptin signaling (db/db) or lack endogenous leptin (ob/ob) to evaluate how obesity and
leptin signaling within cancer cells and within the tumor microenvironment influence resistance to radiotherapy.
In specific aim 1 we will examine the effects of obesity on the efficacy of RT and also examine the direct effects
on the tumor as well as the indirect effects via T cell dysfunction or other immune mechanisms. In specific aim
2 we will investigate leptin signaling as an underlying mechanism whereby obesity induces resistance to RT both
through direct effects on cancer cell proliferation / survival and also through indirect effects on the TME. In
specific aim 3 we will test an exploratory hypothesis that ablative RT is able to improve RT efficacy in obesity by
overcoming the mechanisms of obesity induced direct (but not immune related indirect) RT resistance.
Understanding how obesity impacts RT response and developing strategies to address these issues will
improve outcomes in obese patients treated with RT. Thus, these studies can have a major clinical impact
and represent a step towards personalized medicine by tailoring RT treatment strategies to a patient's metabolic
parameters.

Public health relevance
Narrative Obesity will soon be the leading cause of preventable cancers and a large proportion of cancer patients are obese, but little is understood about how obesity influences the effectiveness of cancer therapy. Clinical studies as well as our pre-clinical data show that obese cancer patients are more resistant to radiotherapy and have higher rates of cancer recurrence. Based on our previous data showing that obesity profoundly impacts tumor biology we will examine mechanisms inducing radiotherapy resistance and how to improve outcomes in obese patients.